NATURAL HISTORY OF HIV-1 INFECTION IN A LONGITUDINAL COHORT OF GAY/BISEXUAL MEN

Ongoing natural history study of the transmission, clinical manifestations, immunologic and virologic characteristics of HIV-1 infection.